SHS - MBIRI FC - SUBTASK B.2 PHASE VII EXAM AND EXAM CLOSEOUT.

During subtask B.2, the Contractor shall prepare for, recruit, and perform a limited re-examination of all surviving and willing SHS participants for Phase VII. The targeted recruitment is approximately 80% of all surviving and willing SHS participants; assume up to approximately 944 participants from the Dakota Field Center for the exam.